STRUCTURE AND INTERACTIONS OF BIOLOGICALLY IMPORTANT MACROMOLECULES

Cooperative binding systems involving aggregation, redistribution, subunit interactions, and ligand interactions are being formulated and studied in proteins and model compounds. Monte Carol analyses are done to yield probabilities for uniqueness and homology of amino acid sequences. Our present studies in this area are concentrated on the relationship of uniqueness and the immune response.